Myeloid sphingolipid regulation of tissue resolution and regeneration responses

SUMMARY
Myeloid cells of the innate immune system (neutrophils and macrophages) interact closely with the
vascular endothelium to modulate inflammatory and resolution responses. During early stages of the
inflammatory response, inappropriate neutrophils activation causes vascular and parenchymal injury.
However, in late stages of inflammation, precisely-controlled neutrophil resolution mechanisms are now
considered to be critical to limit tissue damage and initiate regeneration of new vascular channels and
parenchymal tissues. Even though neutrophil function in early stages of inflammatory processes is well
understood, their involvement in resolution responses is poorly understood. We have found that the
sphingosine 1-phosphate (S1P) receptor-1 (S1PR1), a G protein-coupled receptor (GPCR) with
well-established functions in vascular and adaptive immune (T and B) cells, regulates neutrophil resolution
responses. Specifically, S1PR1 signaling induces a non-inflammatory, long-lived neutrophil phenotype that
undergoes efficient phagocytosis. We also found that this novel and unappreciated function of neutrophil
S1PR1 signaling axis is critical for efficient recovery from virus-induced lung injury and chemical-induced acute
liver failure. To activate this beneficial process, we developed a novel biologic based on our knowledge of S1P
chaperones. We hypothesize that local S1PR1 signaling in neutrophils is a general mechanism that resolves
inflammatory tissue injury and thus enable vascular and parenchymal regeneration in multiple organ systems.
Furthermore, we posit that therapeutic activation of this signaling axis may provide a novel strategy to control
chronic smoldering inflammation that lead to fibrotic diseases and organ dysfunction. To test this hypothesis,
we will examine GPCR proximal mechanisms and nuclear transcriptional events that are regulated by S1PR1
in tissue neutrophils during resolution responses. Second, we will examine the importance of this signaling
axis in resolution responses that are induced after virus-induced lung injury and chemical-induced liver injury in
mouse models. Third, we will obtain proof-of-concept data to activate this signaling axis that utilize engineered
designer HDL particles that contain ApoA1 and ApoM to stimulate neutrophil resolution responses and
enhance vascular endothelial survival and regeneration. These data are anticipated to reveal novel
mechanisms of resolution processes and enable innovative therapeutic strategies to control chronic
inflammatory diseases.

Public health relevance
NARRATIVE Inflammation is a protective process that must be terminated in a timely manner by the processes of resolution to achieve organ system health. We have identified a new mechanism by which the lipid mediator sphingosine 1-phosphate (S1P) acts on neutrophil S1P receptor-1 to induce resolution processes and achieve organ health after viral and chemical insults. This proposal will help clarify this poorly understood mechanism and develop new therapeutic approaches to control tissue damage of various organ systems.